CORRELATIVE BRAIN MRI/SPECT SCANS IN CNS OF SJOGREN'S SYNDROME PATIENTS

Correlation of neuroanatomic abnormalities on brain MRI scans and regions of cerebral cortical hypoperfusion on brain HMPAO SPECT scans with neurologic deficits, cognitive dysfunction, and anti-Ro(SS-A) antibodies in CNS-SS.